Data-Management-Core

PROJECT SUMMARY- CORE B
The Data Management and Sharing (DMS Core) will be integral to the Bunyavirus and Picornavirus Pandemic
Pathogen Preparedness (BP4) Center. The DMS Core will support the BP4 investigators by providing
infrastructure to manage and secure scientific data originating in all BP4 ReVAMPP projects and cores. This
core will ensure secure access to shared data for all investigators, oversee preservation and archiving of data in
the BP4 consortium and in public databases. The DMS Core will also foster a collaborative environment within
the BP4 Center and the ReVAMPP network by coordinating and assisting investigators with depositing data in
repositories and ensuring the center adheres to FAIR practices, including sequence depositions to the Short
Read Archive and GenBank, immunology data to ImmPort, epitope data to the Immune Epitope Database (IEDB),
and structural data to the Protein Data Bank and Electron Microscopy Data Bank (EMDB). The DMS Core will
work closely with the Coordination and Data Sharing Center (CDSC) to comply with data sharing expectations
of the ReVAMPP Network. Biostatistical support for the center’s research projects and scientific cores, provided
by a Ph.D.-level biostatistician with a high level of expertise in immunology and infectious diseases expertise,
will also be an activity of the DMS Core. This support will guide the center’s investigators to approaches that will
result in quality data.